GENCODE: comprehensive reference genome annotation for human and mouse

Project Summary
The GENCODE consortium creates foundational reference genome annotation for the human and mouse
genomes in which all features are identified and classified with high accuracy based on biological evidence, and
then freely released for the benefit of biomedical research and genome interpretation. GENCODE seeks to
create annotation that increases the understanding of genome function in both human and mouse by prioritizing
human disease genes and respecting the role of mouse as the major mammalian model organism. To effectively
annotate genomes, GENCODE has created a suite of tools and draws on deep expertise across its partners
across four fundamental components: 1) a comprehensive gene annotation pipeline leveraging manual and
computational annotation; 2) a set of computational methods to evaluate and enhance gene annotation; 3)
experimental pipelines targeted to expressed sequences less detectable in standard protocols; and 4) a machine
learning capacity to improve all facets of the project. GENCODE will maintain a major focus on protein-coding
and non-coding loci, including their alternatively spliced isoforms and pseudogenes and will extend expert
manual review to small non-coding RNAs (ncRNA) and the annotation of non-polyadenylated transcripts.
GENCODE will also expand regulatory annotation to a defined set of gene-associated features to more
accurately reflect the interconnections between regulatory regions, including those with transcribed sequences
such as ncRNA, and overall transcriptional output. GENCODE will take advantage of the increasing maturity of
genomics technology including long-read transcriptome sequencing, functional genomics assays, and graph-
based genome representations to identify features such as genes, pseudogenes, exons and splice sites that are
incorrect, incomplete or in genome regions simply not present in the current reference assembly. More
specifically, in the next four years GENCODE plans to 1) extend its human and mouse gene sets to as near
completion as possible given available data and current experimental technology; 2) leverage new, high-quality
human genome assemblies and targeted transcriptomic data to expand representation so that more human
haplotypes will have high-quality annotation 3) annotate gene-associated regulatory regions including enhancer-
promoter connections 4) collaborate with other resources to ensure a consistent representation of genic and
regulatory features and reference transcripts for reporting clinical variation; and 5) distribute GENCODE
annotations and engage with community annotation efforts to ensure accuracy and consistency. Primary
GENCODE data will continue to be available from the Ensembl and UCSC Genome Browsers and the
GENCODE web site. We will develop new mechanisms for effective two-way outreach, training and
communication with the community with the long-term aim of establishing GENCODE as the standard annotation
set for research and clinical genomics applications.

Public health relevance
Project Narrative The GENCODE project produces reference genome annotation for the human and mouse genomes. The annotation provides a reference from which to conduct clinical and genomics research in the short term; in the long term it informs all research that will contribute fundamental knowledge to benefit public health.